Pathogenic and Protective T cells in Toxoplasmosis

DESCRIPTION (provided by applicant): A successful cellular immune response to Toxoplasma gondii and many other intracellular pathogens involves a delicate balance between the actions of IL-12, a pro- inflammatory innate cytokine triggered by the parasite and IL-10, a regulatory cytokine produced by adaptive T cells to prevent immunopathology. The overall goal of this proposal is to explore how IL-12 controls the generation and persistence of parasite- reactive CD8 effector and memory cells required for protective immunity and how IL-10 acts in a novel autocrine fashion to avert tissue damage. Using a new mouse model with T-cell lineage specific interference in IL-10 signaling, we have obtained evidence that IL- 10 activation of a T-cell intrinsic anti-inflammatory response is required to prevent morbidity and mortality during T. gondii infection. We will use this transgenic and other knockout mouse models to elucidate the kinetics, regulation and functional consequences of IL-10 responsiveness during the Th1 response to T. gondii and explore a novel mechanism for how IL-10 cell-autonomously restrains Th1 cytokine responses. We have recently described four subpopulations of CD8 cells induced by immunization with the cps-vaccine strain of T. gondii and have published evidence that IL-12 is critically required for the generation of effector CD8 T cells expressing IFN3, granzyme B and KLRG1. In collaboration with Dr. Hidde Ploegh's laboratory at MIT, we have identified the first Kb-restricted CTL epitope from T. gondii and our collaborators have also developed a cloned mouse line bearing monoclonal naove CD8 T cells reactive to this Kb- restricted T. gondii antigen. Using these new mouse and immunological reagents, we will elucidate the cytokine requirements, lineage relationships and functional significance of the heterogenous CD8 T cell subsets induced by T. gondii vaccination and infection. We will critically assess the costs and benefits of IL-12 signaling on the immediate and recall CD8 protective response to re-infection.

Public health relevance
PUBLIC HEALTH RELEVANCE: Disease caused by parasitic protozoa and other intracellular microbial agents are major causes of mortality and morbidity worldwide. Morbidity and mortality may be caused by immunodeficiency leading to tissue destruction by the parasites or these may result from an overzealous or dysregulated immune response. The studies proposed here will provide new insights into how potentially pathogenic Th1 cells are restrained and how protective CD8 T cells are generated and maintained over the long term, specifically with respect to how cytokines control these immune processes. Insights from these investigations may become useful for vaccination strategies and the management of inflammatory and infectious diseases. Relevance: Disease caused by parasitic protozoa and other intracellular microbial agents are major causes of mortality and morbidity worldwide. Morbidity and mortality may be caused by immunodeficiency leading to tissue destruction by the parasites or these may result from an overzealous or dysregulated immune response. The studies proposed here will provide new insights into how potentially pathogenic Th1 cells are restrained and how protective CD8 T cells are generated and maintained over the long term, specifically with respect to how cytokines control these immune processes. Insights from these investigations may become useful for vaccination strategies and the management of inflammatory and infectious diseases. __SpecificAimsTextDelimiter__ A.SPECIFIC AIMS The intracellular protozoan parasite, Toxoplasma gondii is an important opportunistic pathogen of humans and animals. A successful immune response to T. gondii requires the generation of Th1- type CD4 T cells and effector/memory CD8 T cells(1, Yap, 1999 #90, 2). Nevertheless, unimpeded stimulation of cytokine production by Th1 cells has the potential to cause tissue damage and immunopathology. IL-10 has been shown to be critical for modulating the pro-inflammatory cytokine response required for the restriction and destruction of infectious agents by immune effectors. In the absence of IL-10, CD4 Th1 cells express a latent immunopathogenic phenotype (3). Recent studies have shown that CD4 Th1 cells themselves are the critical source of IL-10 in toxoplasmosis and infectious diseases. Using a novel transgenic mouse model of T-cell specific IL-10 signaling blockade, we have obtained evidence for a vital role of T-cell intrinsic IL-10 signaling in restraining IL-12 signaling and Th1 cytokine production, independent of IL-10's actions on the innate antigen- presenting cell compartment. Thus, IL-10 produced by Th1 cells could act in an autocrine/paracrine fashion to dampen Th1 responses by activating a T-cell intrinsic anti-inflammatory response program. Despite the obvious importance of this negative feedback regulatory system in optimizing anti-microbial immunity and minimizing host pathology, key questions remain unresolved regarding the kinetics and regulation of IL-10 responsiveness in Th1 cells responding to an infectious challenge and the molecular mechanism(s) activated by IL-10 within T cells to implement an anti- inflammatory regime. Our hypothesis is that IL-10 induces a transient state of refractoriness to IL-12 signaling to dampen and modulate an ongoing Th1 cytokine response. We have recently defined four distinct subpopulations of CD8 T cells induced by vaccination with the uracil-auxotrophic strain of T. gondii and have published that IL-12 is critical for driving the differentiation of effector CD8 T cells expressing IFNγ, granzyme B(GrB) and KLRG1(4). In collaboration with colleagues from MIT, we have also identified the first Kb-restricted CD8 epitope for T. gondii and have developed a cloned mouse lineage with naïve T cells expressing the T cell receptor specific for the Kb-restricted epitope of T. gondii. Using these new mouse and immunological reagents, we will elucidate the cytokine requirements, lineage relationships and functional significance of the heterogenous CD8 T cell subsets induced by T. gondii and critically assess the benefits and costs of IL-12 signaling on the immediate and long term protective responses mediated by CD8 effector/memory cells. Two major aims are proposed for this project: 1. Define the role and function of autocrine/paracrine IL-10 signaling in T cells in preventing immunopathology during toxoplasmosis. Hypothesis: Autocrine/paracrine IL-10 signaling is essential for curtailing T cell responsiveness to innate IL-12 and for averting immunopathology in toxoplasmosis. The mechanism involves transcription induction of gene(s), which principally modulates T cell IL-12 responsiveness. 2. Define the role of IL-12 cytokine signaling in driving heterogenous effector CD8 T cell differentiation and evaluate its impact on effector and memory responses to T. gondii. Hypothesis: Innate IL-12 signaling drives the differentiation and maturation of heterogenous populations of effector CD8 T cells responding to T. gondii, at the expense of central memory cells required for long term immunity.